Core A - Leadership and Administration Core

Core A: Leadership and Administration Core—Abstract
The Leadership and Administration Core (LAC) will provide scientific direction and organizational oversight to
the entire Health, Aging and Dementia in South Africa: A Longitudinal Study (HAALSI) Program. LAC
leaders and associates will be responsible for the scientific integrity of every stage of each project and the
supporting work of the cores. The LAC is comprised of a hierarchy of three PIs, an Executive Committee, an
External Advisory Committee with balanced South African and international representation, and core
administration. The LAC will support each of the four projects and two other cores by establishing regular,
responsive communication systems, and providing effective problem-solving, technical, and methodological
support; supervision and administrative management; and research dissemination pathways. The LAC will also
be responsible for the fiscal health of each project and core and the HAALSI Program overall. Finally, the LAC
will provide effective engagement with Health and Retirement Study (HRS) sister studies; the South African
Population Research Infrastructure Network (SAPRIN); the MADIVA project (Multimorbidity in Africa: Digital
Innovation, Visualisation and Application) funded through DS-I Africa (Harnessing Data Science for Health
Discovery and Innovation in Africa); African Wits-INDEPTH Partnership for the Genomic Study of Body
Composition and Cardiometabolic Disease Risk (AWI-Gen)/Human Heredity & Health in Africa (H3Africa), and
other affiliated scientists, in an effort to harmonize approaches with other global aging studies and population
health research initiatives in South Africa.